DCTD - caNanoLab Nanomaterials Database Expansion

This request is to expand usability of caNanoLab database (https://cananolab.nci.nih.gov/caNanoLab/#/). caNanoLab is a cancer nanomedicine data repository supporting nanotechnology programs within NCI. The expanded support facilitated by this request will enable database expansion and increase data access and usability to the research community.